Dissecting the functional roles of cardiac lymphatics in ischemic heart disease

SUMMARY
Myocardial infarction (MI) is a major cause of morbidity and mortality worldwide. Therefore, seeking new
therapeutic approaches is still the priority in the field. Recent studies have shown that stimulation of lymphatic
growth (lymphangiogenesis) after ischemic heart disease improves cardiac function and attenuates adverse
cardiac remodeling, and cardiac lymphangiogenesis likely improves heart repair after injury by improving the
clearance of inflammatory response. Furthermore, my published work has unraveled a novel additional
mechanism that an “active”, pro-survival paracrine signaling (lymphoangiocrine, Reelin) from lymphatic
endothelial cells promotes cardiomyocyte (CM) survival after injury, a result challenging the traditional view that
lymphatics function as a “passive” route for fluid transport. However, the detailed mechanism/s by which
increased lymphangiogenesis improves heart repair is not yet fully understood. Our exciting preliminary data
suggest that lymphangiogenesis improves cardiac repair requires both, cardioprotective lymphoangiocrine
signals and efficient lymphatic immune clearance function. This proposal is set out to use a various valuable
animal models to determine these functional roles of cardiac lymphangiogenesis during cardiac repair. In the
Aim 1 of the proposal, we will determine the molecular pathways and targets how cardiac lymphangiogenesis
improve CM survival after MI. In the Aim 2 of this proposal, we aim to use a variety of lymphatic loss- and gain-
of function mouse strains to characterize in details the lymphatic functions during cardiac repair, and determine
the therapeutic potential of these optimal effects in treatment of ischemic disease. These fundamental findings
will impact diverse fields including lymphatic biology and cardiovascular research, with an ultimate goal to
identify novel targets for the treatment of cardiovascular diseases.

Public health relevance
NARRATIVE Heart failure is still the major cause of death worldwide, with a pressing need for new therapeutic approaches. Recent studies reported that stimulation of lymphatic growth improve heart function in ischemic heart disease, however, the mechanisms have not been fully understood. In this proposal, we will take advantage of variety lymphatic loss- and gain- of function mouse strains to characterize in details the lymphatic functions during heart injury progression, and determine the underlying mechanism by which lymphatic vasculature improve cardiac repair.